Improving Postpartum Contraceptive Decision-Making Among Women With Substance Use Disorders

The reproductive health needs of women with substance use disorders (SUDs) are unmet. Over 80% of
pregnancies among women with SUDs are unintended, compared to 45% of the general population, and over
20% of women with SUDs have had a short interpregnancy interval (i.e. pregnancy within 18 months of a
previous birth). Pregnancy is a unique opportunity to address contraceptive needs due to increased healthcare
access from expanded Medicaid eligibility, increased access to highly effective contraceptive methods such as
long-acting reversible contraception (LARC) and enhanced motivation to avoid rapid, repeat pregnancy. Despite
this, over 75% of women with opioid use disorder fail to use postpartum contraception and less than 2% receive
LARC in the postpartum period. Currently, there are no effective strategies to improve postpartum contraceptive
decision-making for women with SUDs. To address this gap, we will conduct a hybrid type 1 effectiveness-
implementation randomized controlled trial among 350 postpartum women with SUDs to test the effect of a novel
patient-centered, reproductive planning decision support tool, developed by the research team, called MyPath on
postpartum contraceptive method choice and continuation, continuous contraceptive use, unintended pregnancy
and interpregnancy interval until 18 months postpartum. The primary research aims are to 1) assess the effect of
patient-centered, reproductive planning decision support (MyPath) on postpartum contraceptive utilization and
reproductive health outcomes among women with SUDs; 2) determine if the relationship between MyPath and
contraceptive utilization is mediated by decision quality; and 3) identify barriers and facilitators to integrating
MyPath into routine postpartum clinical care. This research is significant because using a patient-centered,
reproductive planning approach to contraceptive decision-making represents a paradigm shift in both how we
frame and approach reproductive health outcomes among women with SUDs. Our findings will have high impact
if successful as decision support tools are a low-cost, scalable solution that can be used in most clinical settings
and our study design enhances the potential for rapid translation of our findings into routine clinical practice.
Finally, it is feasible because it builds on prior work by a research team with expertise in decision sciences,
implementation, family planning, obstetrics and SUDs.

Public health relevance
The rate of unintended pregnancy among women with substance use disorders (SUDs) is twice that of the general population and is perpetuated by low rates of contraceptive use, especially in the postpartum period. This research will determine the effect of a novel, patient-centered, reproductive planning decision support tool called MyPath on postpartum contraceptive utilization and reproductive health outcomes (i.e. unintended pregnancy, short interpregnancy interval) among women with SUDs. Findings from this research will provide high-quality evidence about how to improve postpartum contraceptive decision-making for women with SUDs and if successful, will identify a low-cost scalable solution that can be implemented in most clinical settings.